GPR35 function in the immune system

Project Summary/Abstract
The precise control of granulocyte migration is critical for fighting off infection and for avoiding
excessive tissue damage. In preliminary work we have obtained evidence for a new chemoattractant receptor,
the metabolite-responsive receptor GPR35, having an important role in the trafficking of two types of
granulocyte to sites of inflammation.
Neutrophils are the major early responders of the innate immune system. Recruitment of neutrophils to
the inflamed peritoneum has served as an important model for studying neutrophil trafficking. Neutrophils move
from blood into the peritoneum via specialized blood vessels in the omentum. We have found that GPR35-
deficient neutrophils are less efficiently recruited to the inflamed peritoneum and this reflects less efficient entry
into this abdominal tissue site. We propose that neutrophils respond to GPR35 ligands soon after attachment
to the inflamed omental endothelial and that GPR35 signaling contributes to transmigration across the
endothelium. We will test this hypothesis using whole mount and real time imaging studies of omentum. Our
preliminary data indicate that GPR35 function in thioglycolate elicited peritoneal inflammation depends on type
I IFN. We will determine what cell types must respond to type I IFN for GPR35 function using IFNAR floxed
mice and various Cre-driver mouse lines. This work will help determine which cell types are a source of GPR35
ligand(s). Our preliminary data show a similar GPR35-dependence of neutrophil recruitment to inflamed lymph
nodes (LNs). Similar approaches will be used to study how GPR35 contributes to neutrophil LN homing.
A second granulocyte type that highly expresses GPR35 is eosinophils. Eosinophils are recruited to
sites of type 2 inflammation whether they can have profound influences on tissue homeostasis. Cryptococcal
neoformans is an opportunistic fungal pathogen that can cause fatal disease in severely immune compromised
individuals. Protection from Cryptococcal growth in the lungs is mediated by type 1 immunity. By contrast, type
2 immune responses and recruitment of eosinophils is associated with exacerbation of disease. We have
found that GPR35-deficient mice have improved protection from Cryptococcal infection. In preliminary
experiments we find that GPR35-deficiency is associated with lower recruitment of eosinophils to the infected
lung. In Aim 2 of this exploratory study we will begin to define the basis for the improved Cryptococcal
clearance in GPR35-deficient mice and test for intrinsic roles of GPR35 in eosinophils.
The work will define the step that GPR35 functions at during neutrophil recruitment, it will begin to
define the sources of GPR35 ligand, and it will elucidate how GPR35 negatively impacts on Cryptococcal
clearance from the lung. These findings will provide a framework for more broadly understanding GPR35
function in vivo, and they will establish a rationale for the therapeutic development of GPR35 antagonists.

Public health relevance
Project Narrative This work will define how GPR35 contributes to neutrophil entry into inflamed tissues and it will characterize cell types involved in GPR35 ligand production and test whether kynurenic acid is a physiological ligand for neutrophil recruitment. The project will also determine how GPR35-deficiency leads to better control of Cryptococcal neoformans infection, including experiments to test the role of GPR35 in eosinophil recruitment to the lungs. Findings from this work will help determine under what conditions GPR35 may be antagonized for therapeutic benefit.